RelianceET: a novel endotracheal tube design with a superior sealing mechanism to improve clinical efficiency and reduce lung injury and infection for patients.

Abstract
Every year in the United States, nearly 500,000 patients develop an infection on a
ventilator, of which an estimated 1 in 3 die. Ventilator-associated infections are the leading cause
of mortality in the ICU and add $8B to US healthcare spending annually. Caring for patients on
ventilators is multifactorial, but the driver of infection is silent aspiration (harmful fluid entering
the airway without a patient response like coughing). Endotracheal tubes (ETTs) facilitate
mechanical ventilation, and patients must rely on ETTs to prevent aspiration. For the last 50 years,
ETTs have used an inflatable balloon to create a seal in the airway to prevent silent aspiration. The
problem is that these balloons often fail by creasing, deflating, or migrating, which allows harmful
fluid to enter the lungs, increasing the risk of infection for ventilated patients.
To solve this problem, Respair developed RelianceET, an ETT that replaces the error-
prone balloon with ultra-soft baffles (thin, flexible discs). The baffles gently fold along the trachea
wall to comprehensively seal the airway while exerting less force than a balloon. In preliminary
testing, RelianceET was 98% more effective than current ETTs in preventing leaks. Respair
conducted over 100 interviews with clinicians and purchasers to map the needs of key
stakeholders. Respair also met with FDA to validate novel safety test protocols for this SBIR. What
remains unknown is if the baffle sealing mechanism is safe and effective across adult airway sizes.
This SBIR has two specific aims to achieve critical milestones that assess the feasibility of
RelianceET in adult airways. Aim 1: Complete comprehensive leak, tracheal force, and
ventilatory pressure tests on prototypes in preparation for FDA submission. Respair will test
RelianceET prototypes using novel protocols to quantify critical safety metrics that validate the baffle
sealing mechanism across adult airway sizes. Aim 2: Evaluate the insertion and removal forces
of ETTs on a novel benchtop model that includes the larynx (vocal folds) and trachea. Respair
will develop and use 3D-printed airway models to compare the insertion and removal forces of
RelianceET versus current ETTs. The models also quantify forces exerted on the vocal folds. During
interviews, Respair found that comparative force data is required to convince stakeholders.
Completing these objectives will validate RelianceET’s technical feasibility and safety,
enabling Respair to reach a final design freeze. Respair aims to create a new standard for critical
care by commercializing a safer and more effective endotracheal tube to improve outcomes for
vulnerable patients on ventilators.

Public health relevance
Project Narrative Every year silent aspiration during ventilation leads to nearly 500,000 pulmonary infections with a mortality rate of 1 in 3, adding more than $8 billion to healthcare spending in the United States. Respair is developing a novel endotracheal tube with ultra-soft baffles (thin, flexible discs) attached to the tube to create a seal that prevents silent aspiration while putting less force on the airway than current balloon sealing mechanisms. Respair aims to validate the baffle design through FDA verified safety and usability tests that will support the commercialization of a new device for patients on ventilators and create a technology platform for airway device innovation that further improves patient outcomes and reduces healthcare costs.